Family-Centered Implementation of Parent Training for Emotion Regulation in Autistic Toddlers within the Part C Early Intervention System

PROJECT SUMMARY/ABSTRACT: The objective of this K23 career development grant is to help the
applicant acquire the skills needed for an independent research career as an innovative implementation
scientist focused on increasing equitable access to autism-specialized supports aligned with individual family
needs within the context of complex service systems. It will achieve this by building on the candidate’s
background in clinical science, developmental psychopathology, and intervention research with mentorship in
health equity, intervention adaptation, mechanisms and system-level factors of implementation, and
professional development. The IDEA Part C Early Intervention (EI) system is ideally situated to provide family-
centered intervention to children from birth to three years. Autism spectrum disorder (ASD) is highly prevalent
among children served by Part C. However, Part C EI providers receive little systematic training in areas of
impairment related to ASD, including emotion dysregulation (e.g., meltdowns, aggression). These types of
challenging behavior are a prominent aspect of ASD in toddlerhood, but are often misdiagnosed and over-
pathologized in children of color, especially Black children. This proposed K23 will address these gaps in EI
provider training and in family access to autism-specialized services by implementing a highly evidence-based
practice (Parent Training) in Part C with toddlers with autism (Aim 1) as well as mechanistically understanding
whether family and provider readiness (Aim 2), and system level characteristics (Aim 3) may enhance future
high-quality Parent Training within Part C. With primary mentorship from Sarabeth Broder-Fingert, MD MPH,
and Jane Roberts, PhD, and co-mentorship from Donna Coffman, PhD and a consultant team, the applicant
will pursue training in: (1) implementation methods that foster healthcare equity; (2) adapting interventions for
sustainable use within systems; (3) mechanisms of effectiveness and implementation (e.g., causal modeling,
adaptive treatment design); (4) system-level implementation factors (e.g., cost effectiveness, policy); and (5)
building a strong, grant-funded research program. Training in these areas will enhance and be enhanced by
the completion of research aims: Aim 1, Assess the feasibility, acceptability, cultural responsiveness, and
preliminary effectiveness of Parent Training versus EI practice as usual; Aim 2, Examine whether EIs’ and
caregivers’ readiness to implement Parent Training strategies predicts their fidelity to and intent to use Parent
Training; and Aim 3, Prepare for implementation at scale by identifying implementation supports for Parent
Training within the Part C context. This proposal is aligned with the NIMH’s strategic objective 4.2.B., “Building
models to scale-up evidence-based practices for use in public and private primary care, specialty care, and
non-traditional settings.” Completing the substantive training and research goals within this K23 proposal will
position the applicant as an independent researcher who conducts hybrid effectiveness-implementation trials of
supports for both social communication and emotion regulation in public healthcare systems.

Public health relevance
PROJECT NARRATIVE: In this K23 career development grant, the PI will build on her training as a clinical scientist and learn to: use implementation methods that foster healthcare equity; adapt interventions; explore mechanisms of both effectiveness and implementation by using causal modeling and adaptive treatment designs; and evaluate the system-level aspects of sustainable implementation (e.g., cost effectiveness, policy determinants). To enhance these training goals, she proposes a study that introduces Parent Training for emotion regulation in autism into the Part C EI system, determines its feasibility and preliminary efficacy in this setting, and assesses what family, provider, and system-level factors may facilitate the uptake of parent training in Part C. The proposed research aligns with Strategy 4.2.B of the NIMH strategic plan, “Building models to scale-up evidence-based practices for use in public and private primary care, specialty care, and non-traditional settings,” by assessing the feasibility of implementing an EBP within Part C, a free-to-families public healthcare system.